Chemical Approaches to Protein Arginine Methylation

DESCRIPTION (provided by applicant): Protein arginine methyltransferases (PRMTs) are a relatively new type of chromatin-modifying enzymes that catalyze the methylation of specific arginine residues in histone and nonhistone substrates. Aberrant expression of PRMTs has been observed in various human diseases. However, the biological impact of protein arginine methylation and the molecular basis of PRMT catalysis are poorly defined. Our long-term research goal is to elucidate the biochemical pathways mediated by key PRMTs that contribute to the pathogenesis of cancer and cardiovascular disorders, and to develop effective PRMT inhibitors. In this proposal, we plan to carry out studies on mechanism, regulation, and function of key PRMT enzymes, by exploring and applying new chemical biology approaches. Two specific aims will be pursued: a) Design unique biochemical assays to elucidate the mechanism of substrate specificity regulation by PRMT1. The mechanisms that govern the substrate specificity of PRMTs are not well understood. It also remains to determine the dynamic regulation of arginine methylation. We will introduce environmentally sensitive fluorophores to probe how key motifs in the substrates dynamically regulate arginine recognition and methylation. Also, we will use expressed protein ligation to site specifically label PRMT1 with biophysical probes to investigate the conformational changes of PRMT1 during the catalytic process. Further, we will create a semi-active hetero-oligomer of PRMT1 to determine the catalytic role of PRMT1 oligomerization in regulating substrate binding and methylation. The proposed study will yield new non-radioactive assays of PRMT catalysis, provide molecular understanding of PRMT substrate specificity, and offer critical insight for designing specific PRMT1 inhibitors; b) Develop chemical probes to sort out the substrate specificity of PRMT1 in prostate cancer cells. The importance of PRMTs in prostate cancer pathogenesis is increasingly recognized. To reveal the function of PRMTs in the disease, we propose a series of unique chemical biology approaches to investigate the substrate specificity of PRMT1 in both androgen-dependent and androgen-refractory prostate cancer cells. First, we will prepare biotin-labeled PRMT1 to identify PRMT1- interactive proteins, from which substrate candidates will be determined. Second, we will design, synthesize and evaluate AdoMet analogs as chemical probes to investigate cellular substrates of PRMT1. Third, we will create new chemical probes for global mapping of arginine-methylated substrates in prostate cancer cells. The results of the proposed research will be essential for understanding the mechanism and the biological impact of PRMT-catalyzed methylation in gene regulation and signal transduction. Accomplishment of the proposed work will also provide new chemical tools for both basic PRMT biology research and facilitate the development of therapeutic agents for the treatment of carcinoma, cardiovascular disorders, and other diseases related to the deregulation of protein arginine methylation.

Public health relevance
PUBLIC HEALTH RELEVANCE: Malfunctioning of protein arginine methyltransferases (PRMTs) is closely associated with the pathogenesis of various human diseases. We propose a series of chemical biology strategies to elucidate the substrate specificity and enzymatic functions of key PRMTs. This effort is of great significance for the development of potent PRMT inhibitors to treat prostate carcinoma and other diseases associated with the deregulation of protein arginine methylation. Project Narrative Malfunctioning of protein arginine methyltransferases (PRMTs) is closely associated with the pathogenesis of various human diseases. We propose a series of chemical biology strategies to elucidate the substrate specificity and enzymatic functions of key PRMTs. This effort is of great significance for the development of potent PRMT inhibitors to treat prostate carcinoma and other diseases associated with the deregulation of protein arginine methylation. __SpecificAimsTextDelimiter__ Research Plan. Chemical Approaches to Protein Arginine Methylation A. Specific Aims This proposal is a competitive revised application of 1R01GM086717-01A1 concerning the enzymatic mechanism and function of protein arginine methyltransferases (PRMTs). PRMTs are a relatively new type of epigenetic enzymes that catalyze the methylation of specific arginine residues in histone and nonhistone substrates. They are reported to regulate multiple cellular pathways including transcriptional activation, RNA processing, and protein trafficking. Also, deregulation of PRMT expression and activity is observed in various diseased conditions such as carcinoma, viral infection, and cardiovascular diseases. Therefore, elucidation of the enzymatic mechanisms of PRMTs at the molecular level will be critical to understand the functional roles of protein arginine methylation in both normal and diseased states as well as to facilitate designing potent selective PRMT inhibitors for pharmacological intervention. Although much has been learned in recent years about PRMTs, many unanswered questions remain about the nature of methylation, timing of catalysis, substrate specificity regulation, and the biochemical consequence of methyl modification. Of note, the mechanistic studies have been greatly hindered by the intrinsic complexity of multiple arginine methylations and a lack of effective experimental tools that can be used to dissect arginine methylation reaction. In this proposal, we plan to create new chemical biology strategies to elucidate the molecular basis of key PRMTs in substrate specificity regulation and to further discover unknown substrates of PRMTs in prostate cancer cells with the long-term goal of developing PRMT inhibitors as novel therapeutics. Two Specific Aims will be pursued. A1. Specific Aim 1. Design unique biochemical assays to elucidate the mechanism of substrate specificity regulation by PRMT1. The enzymatic function of PRMTs is closely associated with their cellular targets. Therefore, it is critical to understand how protein substrates are specifically recognized and dynamically methylated by PRMTs. PRMT1 is the predominant arginine methyltransferase in mammalian cells. However, to date, the knowledge of PRMT1 substrate specificity is very elusive and incomplete. We propose several unique biochemical assays to elucidate the mechanism of substrate recognition and catalysis by PRMT1. First, we will introduce environmentally sensitive fluorophores to investigate how the amino acid sequences adjacent to the target arginine in the substrates mediate substrate binding and methylation. Then, we will use expressed protein ligation (EPL) to site specifically label PRMT1 with biophysical probes to examine the conformational changes of PRMT1 during the catalytic pathway. Last, we will create a semi-active hetero-oligomer of PRMT1 to determine the catalytic role of PRMT1 oligomerization in regulating the processivity of arginine methylation. These studies will yield new non-radioactive assays of PRMT catalysis, provide a molecular understanding of PRMT substrate specificity, and offer critical insight for designing specific PRMT1 inhibitors. A2. Specific Aim 2. Develop new chemical biology tools to sort out the substrate specificity of PRMT1 in prostate cancer. Existing evidence points towards the significance of PRMTs in prostate cancer pathogenesis. However, the substrate specificity of PRMT1 in prostate cancer is largely unexplored. Identifying the cellular targets of PRMTs will shed insightful light on the still-incomplete PRMT functions in normal and diseased states. To reveal its functional role in prostate carcinoma, we propose a series of novel chemical biology approaches to investigate the substrate specificity of PRMT1 in both androgen- dependent and androgen-refractory prostate cancer cells. In the first strategy, we will make biotin-labeled PRMT1 using EPL to identify PRMT1-interactive proteins, from which substrate candidates will be determined. Secondly, we will design, synthesize and evaluate AdoMet analogs as chemical probes to investigate the cellular substrates of PRMT1. In the third approach, we will develop chemical probes for collective analysis of arginine-methylated substrates in cell lysates. The structure of the probes is composed of a Tudor domain for the recognition of methylated arginine residues, a photocrosslinking group for covalent targeting of PRMT substrates, and a biotin affinity tag for pulldown analysis. These methods have their own unique advantages and will be complementary to one another in the investigation of cellular substrates of PRMT1 in the context of prostate cancer. Furthermore, important PRMT1 targets will be selected for detailed investigation to delineate how PRMT1 regulates key pathways associated the initiation and progression of prostate carcinoma.